Epidemiology Genetics Research Program Meeting Support & Technical Support.

This contract provides meeting planning support for the Epidemiology and Genetics Research Program within the Division of Cancer Control and Population Sciences at the National Cancer Institute. EGRP's mission is to increase our understanding of the determinants of cancer and cancer-related outcomes in human populations.